Pro-Oncogenic Role of a Mitochondrial Lipid Kinase in CLL

PROJECT SUMMARY
Chronic lymphocytic leukemia (CLL) is an adult B-cell malignancy accounting for about a third of leukemia
diagnoses in the US. While B-cell receptor (BCR)-signal-inhibitors are changing the management of CLL, these
are not curative and resistance can develop; often leading to more aggressive disease. Given this, understanding
the molecular events driving CLL oncogenesis and therapeutic resistance warrants in-depth investigation.
CLL is a disease characterized by extensive clonal proliferation and accumulation of malignant B lymphocytes
in the blood, bone marrow, spleen, and lymph nodes. CLL shows remarkable clinical heterogeneity, with some
patients pursuing an indolent course, while others progress rapidly and require early treatment. In the past 10
years, new insights into the biological function of a mitochondrial lipid kinase, acylglycerol kinase (AGK), as a
key oncogene that is highly expressed in a range of tumor types, including prostate cancer, breast cancer,
cervical squamous cell carcinoma, and esophageal squamous cell carcinoma have been established. Most
recently, we found aberrantly high level expression of AGK in CLL cells from ~60% of pre-therapy CLL patients.
However, the mechanism of aberrant upregulation of AGK in CLL cells, and its precise functional contributions
to CLL cell biology and pathogenesis remain unknown. Interestingly, we detected nuclear/cytoplasmic
localization of AGK in some CLL clones suggesting its multi-functional role. In line with this, we found that siRNA-
mediated depletion of AGK in primary CLL cells resulted in marked inhibition of constitutively active multiple
signal mediators including AKT, Erk1/2, LYN, BTK (downstream targets of BCR signal) and JAK2. Our
preliminary findings also indicate that MYC may regulate AGK expression in CLL cells. Our combined data
suggest that aberrant expression of AGK may potentiate cell survival signals including BCR and JAK2 in some
CLL clones resulting in resistance to BCR-targeted therapies. Therefore, the central hypothesis of this application
is that aberrant expression of AGK in some CLL clones represents highly aggressive CLL with shorter time to
therapy. We also postulate that AGK upregulation potentiates CLL cell survival signals and resistance to BCR-
targeted agents. We propose – Aim 1: Evaluate if aberrant expression of AGK in CLL cells drives disease
progression; Aim 2: Define the mechanism of AGK upregulation and its role in CLL cell biology, signaling and
potential as a therapeutic target. The proposed in-depth studies will assess if “high AGK” level in CLL cells serves
as a risk factor for CLL progression, time to therapy and treatment outcome; define the impact of AGK aberrant
expression on CLL cell survival and resistance to current BCR-targeted therapies. Thus, the proposed studies
have enormous potential to establish a new prognostic parameter and therapeutic avenue via targeting AGK in
CLL cells with or without the current BCR-targeted therapy, ibrutinib.

Public health relevance
PROJECT NARRATIVE Relevance to Public Health This grant proposal will develop a robust and comprehensive analysis of the expression status of a previously undefined mitochondrial lipid kinase, AGK, in chronic lymphocytic leukemia (CLL) which we have detected recently in CLL cells however; functional implication of this aberrantly expressed lipid kinase in CLL oncogenesis remains unknown. The proposed studies are dedicated in novel and important directions: 1) to establish if aberrant expression of AGK in CLL cells represents high-risk CLL patients' cohort for aggressive disease and/or predicts time to therapy; 2) delineate the mechanism of AGK upregulation in CLL cells; 3) define the function of AGK in CLL cell survival and therapeutic outcome of the patients and finally, 4) assess the feasibility of targeting aberrantly expressed AGK to induce apoptosis in vitro in leukemic B-cells from previously untreated CLL patients, and in vivo in a CLL-specific established mouse model. In total, the information gained on the aberrantly upregulated AGK in CLL cells in relation to disease progression and our goal on developing increasing rationale for the use of AGK-inhibitor alone or in combination with the current targeted therapies for CLL has great potential to impact and improve public health.